Tumor stem cells and metastatic outcomes in mouse models of prostate cancer

The goals of our project are to isolate prostate epithelial populations, including prostate stem cells, and to evaluate the tumorigenic and the metastatic capacity of such populations upon transformation by genetic mutations that are commonly associated with human prostate cancer. Here we describe our progress in characterizing a mouse model of prostate cancer initiated by prostate epithelial cell specific deletion of the tumor suppressors, Pten and Tp53. Loss of PTEN and loss of TP53 are common genetic aberrations occurring in prostate cancer. PTEN and TP53 contribute significantly to the regulation of adult stem/progenitor cells in somatic tissues, and we hypothesized that combined deletion of these tumor suppressors in prostate epithelium would provide insight into the pathophysiology of transformed prostate progenitor cells. Using the PB-Cre4; Ptenfl/fl;TP53fl/fl model of prostate cancer, we describe the histologic and metastatic properties of primary tumors, of transplanted primary tumor cells, and of clonal cell lines established from tumors. Acquired resistance following treatment of progressive prostate cancer with androgen deprivation therapy is a significant clinical problem. An adaptive mechanism of resistance hypothesizes that castration tolerant stem/progenitor cells are precursors of castration resistant prostate cancer (CRPC) that subsequently develops as a result of mutation and selection. Two properties, stem/progenitor characteristics and intrinsic androgen indifference, are of particular interest because of the mechanistic insight that may be applicable to some aspects of aggressive or advanced human prostate cancer. To address stem/progenitor properties, we analyzed clonal tumor initiating ability and lineage potential.. This demonstrated for the first time in transplantation experiments the capacity for clonal growth from a self-renewing luminal cell. The development of organoid culture technology allowed us to analyze the lineage potential and self-renewing properties of fractionated luminal and basal populations. We determined that relative to WT prostate and Pten-/- tumors, Pten/Tp53 null tumors contained a greatly expanded luminal progenitor population, consisting of mainly luminal-committed cells but also a fraction of progenitors that showed bipotential (luminal and basal) differentiation potential. Finally and importantly, a proportion of self-renewing luminal progenitors are intrinsically resistant to inhibition of AR signaling. We have used orthotopic tumor models of Pten/Tp53 null cell lines to investigate specific questions related to progression of aggressive disease. To interrogate the metabolic alterations associated with survival following ADT, metabolite profiles and associated regulators were compared in tumors from androgen intact mice and in tumors surviving castration. AR inhibition led to changes in the levels of glycolysis and TCA cycle pathway intermediates. As anticipated for inhibitory feedback between AR and PI3K/AKT signaling pathways , pAKT levels were increased in androgen deprived tumors. Elevated mitochondrial HK2 levels and enzyme activities also were observed in androgen-deprived tumors, consistent with a role for pAKT dependent HK2 protein induction and mitochondrial association. Competitive inhibition of HK2 mitochondrial binding in prostate cancer cells led to decreased viability. These data argue for AKT-associated HK2-mediated metabolic reprogramming and mitochondrial association in PI3K driven prostate cancer as one survival mechanism downstream of AR inhibition, and in addition, potentially inform the use of biomarkers and metabolic imaging for monitoring the ADT responses of prostate cancers with documented PI3K/AKT activation. In summary, from our characterization and analysis of the Pb-Cre4;Ptenfl/fl;Tp53fl/fl model we conclude that loss of Tp53 and Pten in Probasin-targeted cells leads to luminal stem/progenitor cell amplification and lineage plasticity. Although the GEMM has limitations with respect to faithfully mirroring human prostate cancer progression, cell lines and primary cells from adenocarcinoma tumors have been useful for establishing concepts concerning a variety of properties expressed by Pten/Tp53 null, poorly-differentiated, androgen indifferent cells. We have used cell lines derived from Pb-Cre4;Ptenfl/fl;Tp53fl/fl tumors in high throughput and focused drug analyses. These screens have revealed vulnerabilities to several drug classes. We have validated sensitivities to gambogic acid and to ganetespib, an HSP90 inhibitor. Gambogic acid appears to act through a mechanism of thioredoxin activity inhibition and ROS generation. Ganetespib inhibits several signaling pathways, including AR and pAKT, which provide compensatory survival signals. More recently, our transcriptomic analysis of organoids initiated from PBCre4;Ptenfl/fl;Tp53fl/fl luminal cancer stem/progenitor cells revealed robust expression of the interferon-related DNA damage resistance signature (IRDS). This tumor associated signature encompasses a subset of STAT1-driven genes, which appear to represent a chronic, feedback-regulated phase of interferon (IFN) signaling. Contrary to acute anti-proliferative IFN signaling, IRDS is associated with promotion of cell-intrinsic therapy resistance. We have produced a triple knockout, PBCre4;Ptenfl/fl;Tp53fl/flStat1fl/fl mouse strain to investigate the role of IRDS on tumor as well as microenvironmental functions. Analysis of human prostate cancer clinical data sets revealed potentially significant correlates with IRDS expression. IRDS was prognostic for progression in the TCGA primary prostate cancer cohort, and high IRDS-expressing CRPC samples in the SU2C data set were enriched for low AR signaling. We currently are using a combination of GEMM and PDX models to characterize the biological context of IRDS expression and to analyze the role of IFN pathway signaling in growth and resistance to clinically-relevant therapies for prostate cancer. Across 15 PDX models, we have analyzed gene expression and protein levels for key constituents in the IFN signaling pathway. We have identified several models with elevated autonomous IFN signaling. To establish the initiation of IFN signaling, we have investigated various upstream initiators, including the cGAS/STING, MAVS, and TBK1 pathways. We are analyzing growth regulation, drug responsiveness, and gene expression in paired parental and genetically modified IFN pathway prostate cancer models.